a2 Collective Coordinating Center Central IRB Option for AITC Pilot Awards

Project Summary
The Coordinating Center for the NIA Artificial Intelligence & Technology Collaboratories (AITC) for Aging
Research undertakes a complementary set of activities to multiply the collective impact of the AITCs to
improve care and health outcomes for older Americans, including persons with dementia (PWD) and their
caregivers. The Specific Aims of the parent grant are to (1) Become a national hub and catalyst for AI and
aging research and development by bringing together the worlds of academia, health, venture, industry, and
government to ensure the successful translation of research to application; (2) create a culture of
coordination, communication, and collaboration with the AITCs, NIA, and relevant NIA research centers and
the broader scientific community; and (3) implement a robust national infrastructure to accomplish and
evaluate the diverse and multifaceted responsibilities of the AITC Program.
A core mission of the AITC program is to identify promising research beyond the traditional academic field
via a national pilot awards competition. As AITC pilot awards are funded for no more than 12 months, it is
critical to ensure timely project initiation to realize results and avoid the need for time extensions and
additional administrative duties. In the first two national pilot awards competitions, the AITCs have received
approximately 500 total applications, with 85% (GY2) to 91% (GY1) of finalists indicating involvement of
human subjects which necessitates review by a responsible Institutional Review Board (IRB). About half of
the finalists are nonacademic institutions, often start-ups, with very little or no experience complying with
complex government regulations and without the institutional support to navigate the NIH and AITC’s
university bureaucracy to proceed with alacrity. Due to this significant need for support in assembling
necessary documents to satisfy IRB review, the AITCs have indicated strong interest for the Coordinating
Center to establish a dedicated IRB specifically to help expedite the review of AITC pilot study protocols
and, in turn, expedite the initiation of the pilot studies. AITCs have committed to work with their own
institution’s IRBs to meet specific institutional requirements to cede oversight to a centralized contract IRB
for non-exempt human subjects research, as needed.
An AITC IRB hub would offer subawardees a supportive, efficient, and coordinated approach that complies
with all government regulations, maintains high ethical standards, and accelerates research innovation.
Centralized IRB assistance provided by the Coordinating Center can ensure that research is not impeded
while harmonizing processes, utilizing a review board with expert-level understanding of the research goals
of the AITCs, and creating efficiencies across the AITC institutions.

Public health relevance
Project Narrative RLA proposes to establish a dedicated central IRB to help expedite the review of healthy aging and AD/ADRD pilot studies for the Artificial Intelligence and Technology Collaboratories (AITC) for Aging Research Program. As the AITC Coordinating Center, RLA is responsible for harmonizing activities across the AITCs. A centralized contract IRB, with the combined support and expertise of Principal Investigators and leadership teams from across all three AITCs and the Coordinating Center, aligns with the mission and scope of the Coordinating Center’s activities and will contribute efficiencies to accelerate innovation. An AITC IRB hub would offer awardees a supportive, efficient, and coordinated approach that complies with all government regulations, maintains high ethical standards, accelerates research innovation, and ensures that research is not impeded while standardizing processes and creating efficiencies across AITC institutions.